Core A (Administrative/Bioinformatics/Statistics)

Core A (Administrative Core) -­ Project Summary

All research projects of this Program Project (PP) will rely on the use of administrative, bioinformatics and
statistical support, which will be directed by Core A. The Administrative Component of Core A will provide
centralized scientific, administrative and financial management as well as computer hardware, software and
network support services (which includes data sharing, storage, and maintenance). The Administrative
Component of Core A will be responsible for monitoring the research progress attained by Projects 1-­4 as well
as the efficient use of Core B by each of the four projects. Core A also will be responsible for general support
of cost areas common to Projects 1-­4 and Cores A-­B. The Bioinformatics and Statistics Component of Core A
will integrate both data generated from Projects 1-­4 as well as publicly available data across a continuum of
assays ranging from cistromics (via ChIP-­Seq), transcriptomics (via RNA-­Seq/microarray), proteomics (RPPA
and DNA-­IP), and metabolomics (via mass spec platforms). Data acquisition will occur in established core
facilities currently in place within the Department of Molecular and Cellular Biology at Baylor College of Medicine.
The Bioinformatics and Statistics Component of Core A will perform primary data analysis, extracting significant
features from each series of OMICs assays proposed in Projects 1-­4. The major contribution of the
Bioinformatics and Statistics Component of Core A consists of integrative analysis, wherein data from multiple
OMICs platforms are combined, leading to comprehensive biological insight and testable hypotheses. Core A
will use data from Encode, the NIH Epigenomic Roadmap, International Human Epigenome Consortium (IHEC),
and scientific data repositories such as the NIH Gene Expression Omnibus (GEO) and Nuclear Receptor
Signaling Atlas (NURSA). For scientific publications, Core A will generate visualizations of these data and results
by employing both off-­line and online software tools. To meet data dissemination guidelines, Core A will perform
data deposition to the appropriate repositories, including but not limited to the NIDDK sponsored NURSA.
Collectively, these efforts will provide the necessary infrastructure to support the various research and core
components of this Program Project application. The successful operation of this administrative team is
unparalleled and is essential to completion of the overarching scientific objectives of our integrative research
teams.